Investigating the link between REV-ERB and HIF-1a in Th17 cell function

SUMMARY
Autoimmune diseases (i.e., rheumatoid arthritis (RA), Type I Diabetes mellitus (T1DM), multiple sclerosis (MS),
Crohn's disease, etc.) affect at least 3% of the US population, although this number appears to be significantly
increasing since 2020. Interestingly, many autoimmune diseases occur disproportionately in women. These
diseases are chronic, debilitating, and often, life threatening. Recent advances in biologic therapeutics have
been successful in reducing symptoms of these chronic diseases in many patients. However, due to the costs
associated with these treatments, many Americans still go untreated. In fact, several recent reports have
described health disparities in women of Hispanic, African American, and Native American descent, due to
availability of healthcare and cost-effective therapies. There is a clear unmet need for lower cost therapeutics
for autoimmune diseases. To develop new therapies for autoimmune diseases, we need to further our
understanding of the physiological and cellular mechanisms controlling activation and differentiation of Th17
cells. Th17 cells are a subtype of CD4+ lymphocytes that produce the pro-inflammatory cytokine interleukin 17a
(IL-17a). Dysregulated activity of Th17 cells is associated with several autoimmune diseases including multiple
sclerosis, rheumatoid arthritis, psoriasis, and others. Many of the current biologic therapies target the
interleukins produced by Th17 cells to reduce aberrant inflammatory processes. HIF-1α is a transcription factor
that plays an important role in the metabolic regulation of Th17 cells. Interestingly, the nuclear receptor REV-
ERB, regulates both the Th17 cell activation and differentiation by competing with RORγt, and recent work by
our lab indicates that REV-ERB may directly repress the expression of HIF-1α, providing a “two-hit” mechanism
to suppressing T-cell mediated autoimmune diseases. This proposal aims to investigate the role that REV-ERB
plays in HIF-1α expression and determine the cellular changes that occur in T-cells during activation with and
without the presence of REV-ERB ligands. The data obtained from this work will provide novel insights to the
role that REV-ERB plays in T-cell physiology, and provide preliminary data for future drug discovery efforts.

Public health relevance
Dysregulation of Th17 cells have been implicated in the pathogenesis of autoimmune diseases including Multiple Sclerosis, rheumatoid arthritis, and colitis. HIF-1α is a transcription factor that regulates metabolic changes in Th17 cells. We have found that the nuclear receptor REV-ERB may regulate HIF-1α, and propose to explore this interaction and subsequent effect of REV-ERB modulation in T-cells.